Pre- and Postdoctoral Training in Toxicology

PROJECT SUMMARY
This is a competing renewal application for the T32 “Pre and Postdoctoral Training in Toxicology” at the
University of North Carolina Chapel Hill (UNC-CH) supporting 8 predoctoral and 3 postdoctoral trainees in the
Curriculum in Toxicology and Environmental Medicine (CiTEM). Our program integrates highly interactive and
productive faculty of basic scientists, physician scientists, and public health researchers from the Schools of
Medicine, Public Health, and Pharmacy at UNC-CH, as well as to outstanding investigators and mentors from
the U.S. EPA and NIEHS in Research Triangle Park. This unique research environment provides students with
cutting-edge training and methodological skills necessary to integrate knowledge in basic biomedical sciences
with next-generation technologies to advance environmental health and toxicology in the 21st century. This
training program includes 43 investigators with an exceptional track record in diverse areas of toxicology and
environmental health research. The four core objectives of this training grant are to provide 1) excellent didactic
training in toxicology and environmental health, 2) networking and professional development opportunities to
support successful research careers, 3) state-of-the-art mentored research opportunities in toxicology and
environmental health, and 4) training in science communication and opportunities for community engagement.
To maintain this successful training program, we continuously update our training approaches, incorporating
feedback from our external advisory committee and other forms of training program evaluation. During the
previous funding cycle we expanded efforts in four specific areas: 1) additional training in high-level data
generation, management, visualization, and analysis methods, 2) engagement in translational research, science
communication, and community outreach, 3) encouraging cross-disciplinary research following the convergence
paradigm, and 4) developing thoughtful approaches for recruiting and retaining trainees from underrepresented
backgrounds. This training grant is led by an experienced team and supported by institutional funds for
administration, faculty recruitment, and trainee activities. This training program takes advantage of the resources
available through several environmental health focused research centers at UNC-CH, including the Superfund
Research Program, the NIEHS-funded Center for Environmental Health and Susceptibility, and the Center for
Environmental Medicine, Asthma, and Lung Biology. Trainees receive specialized training in rigorous research
methodology, research ethics, and scientific/grant writing. They also have ample opportunities to present their
research to local, national, international, or lay audiences. As outlined in this application, our previous record
demonstrates that the outstanding new scientists we train will excel at interdisciplinary approaches that result in
the mechanistic understanding and translation of how the environment influences human disease.

Public health relevance
PROJECT NARRATIVE This interdisciplinary training program is designed to provide the necessary resources, infrastructure, and research opportunities for predoctoral and postdoctoral trainees interested in toxicology and environmental health effects on human diseases. The goal of the Curriculum in Toxicology and Environmental Medicine at UNC-CH is to train new scientists that are able to enhance our understanding of how the environment affects human disease.